Evaluating Neurocognitive Complications of Type 1 Diabetes (T1D) and Potential Risk and Protective Factors in Pre-Pubertal Children- New York University Clinical Center

Project Summary
Children with type 1 diabetes (T1D) have an increased likelihood of mild cognitive dysfunction and altered
brain development compared to healthy children, which can appear soon after disease onset. Younger age at
diagnosis, poorer metabolic control, episodes of diabetic ketoacidosis (DKA), and hypoglycemic events have
been identified as possible risk factors, but how they interact to affect brain development, and who is most
vulnerable remain poorly understood. To investigate the impacts of T1D on cognition and brain development
without interference from puberty, this planned research will enroll as many as 1,000 prepubertal children, half
of whom were diagnosed with T1D within the previous year, and perform MRI and cognitive tests at baseline
and at two-to-three 18-month intervals. Biomedical data will also be collected. Outcomes include cognitive
function and academic achievement, as well as MRI-based microstructural, volumetric, functional and
physiological measures. Their relationship to glycemic variability and multiple biomedical factors will be
assessed. Differences in neurocognitive development between participants with and without T1D will be
compared.
Our team has successfully recruited large, diverse cohorts, including children with and without diabetes, who
have been followed over extended periods of time, recruited from multiple clinical sites, and assessed with a
broad series of biomedical tests, continuous glucose monitoring, neurocognitive and psychosocial measures,
and state-of-the-art neuroimaging techniques. With PIs and Co-Investigators with expertise in neurocognitive
studies in T1D, imaging in young children, management of diabetes in children, data management, quality
control, statistical analysis, cognitive assessments, neuroimaging methods, continuous glucose monitoring,
and stakeholder engagement, our team has the necessary experience to succeed in the proposed study.

Public health relevance
Project Narrative This planned research will enroll a large, diverse cohort of pre-pubertal children shortly after T1D diagnosis, as well as comparison participants without T1D, and assess differences in cognitive function, academic achievement, MRI-based microstructural, volumetric, functional and physiological measures, as well as their relationship to glycemic and non-glycemic factors. We hypothesize that: 1) T1D impacts the developing brain, producing impairments in neurocognitive functioning compared to controls; 2) these impairments are mediated by risk and protective factors, such as magnitude and duration of blood glucose time in range, time spent in hypoglycemia or hyperglycemia, and episodes of severe hypoglycemia and DKA; and 3) indirect effects of hyperglycemia and non-glycemic factors will mediate the effect of hyperglycemia on cognitive function and brain development in children with T1D. The NYU Clinical Center (NYU CC) and the assembled team in this proposal have expertise in neurocognitive studies in T1D, neuroimaging in young children, diabetes management, data management, quality control, statistical analysis, and stakeholder engagement and aim to participate actively and collaboratively with the Biostatistics Research Coordinating Center (BRC), NIH, and other CC clinical sites in designing and implementing the study protocol to engage and follow a diverse population sample of children with recent onset of T1D and then disseminate the findings from the study.